IDeA Networks of Biomedical Research Excellence in Kentucky

KY INBRE Overall Summary
The Kentucky Institutional Development Award (IDeA) Network of Biomedical Research Excellence (KY
INBRE) is a collaborative network of educational institutions working to build capacity for health-related and
biomedical research in the Commonwealth of Kentucky. The KY INBRE network is currently composed of 25
institutions that are geographically distributed across the state of Kentucky. The partner institutions include 2
research intensive universities, and 7 primarily undergraduate institutions (PUIs). Another 16 PUIs participate in
KY INBRE activities. The KY INBRE program is managed by 4 interactive components. The Administrative Core
oversees student research, faculty recruitment, curriculum development, the budget and financial plan, as well
as internal evaluation and reporting. The governance committees provide oversight, evaluation, and guidance to
ensure adherence of the KY INBRE to its mission in building research capacity across the state. The
Developmental Research Project Program provides research funding, mentoring, oversight, and training to
enable KY INBRE faculty to successfully compete for independent NIH funding. The Data Science Core provides
education, training, and equipment access to assist investigators and trainees collect, efficiently analyze, and
share research data. In the next funding cycle, these 4 components will work together to continue to build
biomedical research capacity, strengthen research culture, develop faculty research careers, and provide
students with research opportunities to help develop a strong biomedical research workforce in Kentucky. We
propose to accomplish these goals with the following overall specific aims: 1) provide engaging research
experiences to recruit KY undergraduate students into biomedical science majors/careers; 2) promote research
infrastructure and curriculum development in KY institutions; 3) develop research skills of faculty and trainees to
build research capabilities in KY; and 4) recruit faculty with biomedical research training and provide mentored
career development to build research capacity in KY institutions.

Public health relevance
Project Narrative The goals of the KY INBRE are to build capacity for biomedical research and provide training to develop the research and healthcare workforce in the Commonwealth of Kentucky. These goals will lead to the improved diagnosis and treatment of human diseases.